Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core, directed by Dr. David S. Wilkes, will provide important program services. Core A will be responsible for carrying out the following tasks: 1. Facilitate interactions within the program: Core A will arrange all program meetings. These meetings will include the annual conferences with program personnel and external and internal advisory committees, monthly research meetings of the Pis and their laboratories via video conferencing, and quarterly meetings for Pis via video conferencing to coordinate research efforts, plan new studies and exchange information regarding budgets and programmatic administration. 2. Provide administrative services: The administrative assistant in Core A will work with the Program Director to prepare required NIH and institutional reports, and help with preparation and submission of program manuscripts. The administrative assistant will oversee all budgetary transactions between vendors, universities, the program cores and Pis, as well as tracking budget information for program laboratories. Monthly budget reports will be provided to Pis and the Program Director. Budgetary compliance issues will be addressed by the cores and the Pis. 3. Consultants and external advisors: Four internal advisory committee members have been recruited to the program to complement the efforts of four external advisory committee members. Core A will coordinate travel and record keeping related for consultants and advisors. The external advisory committee members, Drs. Toews, Wright, Mohanakumar, and Bendeck will attend the annual program conference, and advise the program Pis as needed during the year. The external advisors, recognized investigators will visit the program to share advice, technology and collaboration. 4. Federal, state and university reporting: Core A will prepare and transmit reports between institutions and NIH as required. The core will act as the primary liaison between NIH and the program.

Public health relevance
The Administrative Core plays an essential role in program operation to ensure maximal research productivity by: 1) facilitating communication among program personnel; 2) budgetary oversight and tracking; 3) planning and coordinating the visits and communication with program consultants and advisors as well as their institutions; and 4) addressing program compliance at both the institutionial and federal levels.